Role of a novel dynorphinergic extended amygdala circuit in pain- and fentanyl abstinence- facilitated alcohol drinking

PROJECT SUMMARY
Chronic pain is a leading cause of disability worldwide, drastically decreases quality of life, and can drive the
development and maintenance of both alcohol (AUD) and opioid (OUD) use disorders. Both alcohol and opioid
use are reported for pain relief, and co-morbid use of both substances is increasingly common, increasing the
negative effects of either substance used in isolation. Currently, there is limited research, preclinical or clinical,
regarding co-occurring alcohol and opioid use is the context of chronic pain. The kappa opioid receptor (KOR)
and its endogenous ligand dynorphin (DYN) is an endogenous opioid system that is widely expressed throughout
the brain and heavily implicated in alcohol drinking, opioid seeking, and pain chronification. Our lab has recently
identified a novel circuit of nucleus accumbens (NAc) projecting dynorphinergic central amygdala (CeA) neurons
that is modulated by persistent pain and contributes to negative affect. However, this circuit has not been
investigated in alcohol or opioid use. Here, I propose to test the role of DYN CeA-NAc signaling in 1) binge-like
alcohol drinking during persistent pain and protracted fentanyl abstinence, 2) pain avoidance-like behavior and
the effects of alcohol on this behavior, and 3) the effects of binge alcohol on reinstatement of fentanyl seeking
behavior. I will use a combination of behavioral, photometric, and chemogenetic techniques to test the
overarching hypothesis that persistent pain and fentanyl abstinence inhibit a novel dynorphinergic CeA-NAc
circuit to drive binge-like alcohol drinking and subsequent effects on cognitive/motivational pain behaviors and
reinstatement of fentanyl-seeking in a sex-dependent manner. The proposed work will fill a gap in our knowledge
regarding polysubstance use in the context of chronic pain and provide valuable training to a promising young
alcohol neuroscientist.

Public health relevance
PROJECT NARRATIVE Pain can serve as a driving force for the development of both alcohol and opioid use disorders, but the relationships between pain, alcohol, and opioid use and the neurobiological mechanisms underlying these relationship are understudied and poorly understood. This proposal aims to address this gap by utilizing a mouse model of intravenous self-administration to examine the involvement of a novel dynorphinergic extended amygdala circuit in pain- and fentanyl abstinence- mediated binge-like alcohol drinking, and whether binge alcohol modulates reinstatement of fentanyl seeking. The results of this work will fill a gap in knowledge in the fields of addiction and pain research and will provide a platform for immensely valuable training as a future independent scientist in the alcohol research field.